GMCSF AND MURINE MONOCLONAL ANTIBODY R24 FOR METASTATIC MELANOMA

This study will evaluate the in vivo induction of effector cell antibody dependent cellular cytotoxicity (ADCC) in patients receiving GMCSF daily for 28 days followed by R24 antibody; and will evaluate the toxicity and clinical response rate of these drugs to patients with metastatic melanoma.